CONNECT: Collaborative Network for Nurturing Ecosystems of Common Fund Team Science

PROJECT SUMMARY- SUSTAINABILITY CORE
We are an experienced interdisciplinary team who has been a part of the CFDE community since 2014. Our
team offer 20+ years of combined experience in data repositories, data management, cloud computing, and
FAIR data. We are excited for this opportunity to establish the CFDE ICC Sustainability Core (ICC-SC),
to facilitate successful transition of CF program digital assets, including their datasets, software tools
and workflows, as well as e-Learning materials. We are committed to sustain the wealth of knowledge
contributed by the CF programs via education, outreach, and dissemination programs. Our ICC-SC
team will serve as ambassadors to advocate and to champion the grand accomplishments of the CFDE
community. In view of our opportunities and challenges, we propose a CF program digital asset transfer
strategy with 3 specific aims as well as 7 supporting, interconnected, multi-dimensional, and action-packed
milestones and deliverables (see details in the section of Research Strategy).
Briefly, to enable smooth digital asset transitioning efforts and to maximize dissemination and community re-
use, we define five action items to guide CF digital asset transfer: Meet, Assess, Transfer, Coordinate,
Handover (MATCH). Meet. At launch, the ICC-SC, we will invite CF program representatives to meet with
suitable NIH IC-specific, specialized, and public repositories to identify challenges and opportunities in
2-3 matchmaking conferences. Assess. The ICC-SC will help identify needs of both parties to collaborate on a
stewardship plan following the devised diversity, equity, inclusion, and accessibility (DEIA) minded standard
operation protocols (SOPs) for the CF Digital Asset Transfer. Transfer. The process of comprehensive and
secure digital transfer will begin with CF programs creating an inventory for all relevant digital files and
metadata. Coordinate. The ICC-SC will facilitate a transition period, coordinating closely with both parties
to ensure smooth transition of stewardship. The ICC will monitor the secure relocation of assets and
implement backup, versioning, and recovery strategies where applicable. Handover. Following transition,
responsibilities will be handed over to the new steward, with partial ownership by CF programs negotiated
where applicable. To facilitate MATCH, we will construct a web-based application, the “CFDE Digital Asset
Repository Roadmap” linked under the CFDE portal; it will connect CF programs online with suitable IC-
specific, specialized, and public repositories. In collaboration with the Evaluation Core at ICC, we will
implement periodical review of our progress and we will refine our strategy to assure program success
moving forward. In summary, our efforts will showcase CF program success, amplify their impacts, and
extend this invaluable treasure to benefit the wider biomedical community, and to inspire new innovations.